The Influence of Habitual Physical Activity and Diet in the Development of Sarcopenia Among Older Adults With HIV

ABSTRACT
The life expectancy of people with HIV (PWH) in the U.S is increasing. HIV, together with normal aging,
imposes additional challenges to an extended healthspan (i.e., the length of time that the person is
healthy and not just alive) in this population. This includes an earlier occurrence of geriatric conditions
such as sarcopenia, a musculoskeletal disease that can lead to falls, morbidity, loss of independence,
disability, and mortality. Sarcopenia poses a significant economic burden, generating higher healthcare costs
and more extended hospital stays for the sarcopenic population. Sarcopenia is highly prevalent (24%) among
PWH, and we recently demonstrated that PWH are six times more likely to develop sarcopenia than people
without HIV. Despite being prevalent among this population, few observational studies in PWH have
included sarcopenia as a primary outcome, and we lack interventional studies targeting sarcopenia
among PWH. The causes of sarcopenia are multifactorial, and despite being recognized as a debilitating
disease, it has no effective pharmacological treatment. In the general population, physical inactivity and
malnutrition are recognized contributors to sarcopenia, and exercise and diet interventions are the best ways
to prevent and treat it. Among PWH, the causes of sarcopenia can include different HIV-associated factors.
Lifestyle factors such as physical inactivity, sedentary behavior, and malnutrition are prevalent
among PWH and can potentially contribute to sarcopenia in this population. However, these
associations in HIV remain poorly explored, and whether these are the primary contributors to sarcopenia
among PWH is unknown. This proposed study is uniquely positioned to address such gaps in the science by
leveraging the ongoing multi-site PROSPER-HIV study (R01-NR-018391) focused on the association
between physical activity, diet, and HIV symptoms in PWH by adding a whole-body dual-energy X‐ray
absorptiometry scan. This will provide data on the amount of lean body mass and allow us to rigorously
determine the presence of sarcopenia among PWH. The PROSPER-HIV study provides an ideal opportunity
to explore the importance of these modifiable lifestyle behaviors on the healthspan of PWH and to answer
how physical activity and diet can help in the multifactorial development and management of sarcopenia.
Specifically, in 130 PWH ≥50 years of age, we will: 1) Examine the cross-sectional relationship between
modifiable lifestyle factors (i.e., habitual physical activity levels and diet quality) and the presence of
sarcopenia; and 2) Investigate to what extent current or prior exposures (i.e., symptom burden; medication
adherence; smoking, alcohol, and drug use; the presence of depression and anxiety; clinical and
demographic characteristics) predicts sarcopenia. Our scientific premise is that, on top of other factors
leading to HIV-associated sarcopenia, lifestyle factors play an essential role and can be harnesseed as a
non-pharmacologic strategy to reduce the prevalence of this debilitating comorbidity among PWH.

Public health relevance
Project Narrative Non-pharmacological strategies to increase the healthspan and physical functioning of PWH are urgently needed. Our study examines how two promising strategies, habitual physical activity and dietary intake, are associated with sarcopenia in a population at high risk for developing this debilitating musculoskeletal disease. These strategies can be incorporated into ongoing health promotion initiatives in clinics nationwide to help PWH age well.